Flexible Funding Model - Infrastructure Development and Maintenance for State Manufactured Food Regulatory Programs (U18)

Project Summary/Abstract
For
Colorado’s Manufactured Foods Program Flexible Funding Model – Maintenance for
State Manufactured Food Regulatory Programs
It is the intent of the Colorado Department of Public Health and Environment, Division
of Environmental Health and Sustainability (CDPHE-DEHS) to use this opportunity to
manage and maintain conformance with the Manufactured Food Regulatory Program
Standards by implementing the policies, procedures and protocols used by our
Manufactured Foods Program staff when inspecting and regulating the manufactured
foods industry in Colorado. Our goal is to ensure that staff working within the program
is well trained, knowledgeable and will consistently and uniformly apply that
knowledge to the situations encountered while inspecting and providing technical
guidance, education and outreach to the regulated community. In 2015, the
Manufactured Food Regulatory Program Standards (MFRPS) allowed the foundation to
be created and CDPHE was able to develop its own Manufactured Foods regulatory
inspection program. The requirement for states to be in full conformance with the
MFRPS as a condition of continued FDA contractual work and the need to apply these
same standards to the State program will require the dedication of significant
resources that are not currently available to Colorado’s program. We are moving
forward using the standards to strengthen and improve our program by methodically
eliminating the gaps and building a sound sustainable programmatic foundation.
Maintaining a solid program foundation will continue to help improve the program now
and provide guidance for the future.
The goal is to have the work conducted by Colorado’s program be recognized for its
quality and consistency related to inspections, laboratory analytical findings, industry
outreach and staff training. This will allow the agency to meet its goal of Safe Food
provided to Colorado residents and guests as well as to ensure that manufactured food
products that leave the state are safe. The agency is committed to help achieve FDA’s
goal of an integrated food safety system and ensure that Colorado’s inspections,
investigations, laboratory findings and program products are recognized as equivalent
to the work product of other states or the FDA that are using the MFRPS as the basis
for their programs.

Public health relevance
Project Narrative For Colorado’s Manufactured Foods Program Flexible Funding Model – Maintenance for State Manufactured Food Regulatory Programs Colorado’s proposed project and work to conform to the MFRPS will ensure that trained, qualified staff will hold food manufacturers in the state to national food safety standards and food products produced will be safe for consumption. Through conformance with the MFRPS, Colorado will develop and maintain best practices for a high-quality manufactured food regulatory program and enhance food safety by continuing a uniform basis for measuring and improving the performance of the program. These activities will provide FDA the foundation for pursuing regulatory action and improve contracts, inspections, investigations and enforcement to protect public health.